Elucidating the pathogenic mechanisms by which KAT6A mutations alter human in vitro neurodevelopment

PROJECT SUMMARY/ABSTRACT (Limit: 30 lines of text)
Chromatinopathies, defined as developmental disorders caused by germline mutations in epigenetic genes,
present a significant challenge for millions of Americans affected by these 179 rare diseases since ~94% of all
rare diseases do not have treatments available -- highlighting a huge patient population with unmet needs. Our
lab found heterozygous nonsense mutations (i.e. truncating) in the KAT6A gene cause a Chromatinopathy
called Arboleda-Tham Syndrome (ARTHS) that is also referred to as a rare neurodevelopmental disorder.
Although neurological deficits are always observed in ARTHS, the pathogenic mechanisms underlying these
phenotypes are not understood and nothing is known about KAT6A’s functions in human neurodevelopment
(ND). KAT6A is the catalytic subunit of a histone acetyltransferase (HAT) complex that acetylates histones. My
preprint study of ARTHS Cerebral Organoids (COs) describes the consequences of KAT6A deficiency during in
vitro human ND. We show ARTHS COs are delayed in repressing the expression of pluripotency/cell cycle
transcription factors (TFs) during neural differentiation compared to controls -- leading to an overabundance of
cycling neural progenitor cell (NPC) markers in genes upregulated in ARTHS COs. My preliminary data also
shows ARTHS neurons suffer from phenotypic defects like aberrant synapse morphology and metabolic
dysfunction compared to controls. We propose a research strategy to uncover the mechanisms underpinning
our observations in neural models derived from ARTHS patients to elucidate the functional consequences of
KAT6A deficiency during human in vitro ND. I hypothesize during neuronal differentiation, truncating KAT6A
mutations cause reduced KAT6A protein or HAT activity -- leading to altered gene regulation at cell cycle and
ND-related genes via remodeling of histone acetylation and TF binding. I also hypothesize, independent of
these gene regulatory consequences, the loss of KAT6A function negatively affects NPC cell fate & neuron
health through altered proliferation and mitochondrial dynamics, respectively. I will differentiate rare induced
pluripotent stem cells harboring truncating KAT6A mutations and matched controls into NPCs and neurons. In
Aim 1, I will apply complementary functional genomics assays to these cells & perform vertical data integration
to identify the precise mechanisms by which KAT6A deficiency causes aberrant changes in transcription and
chromatin remodeling via perturbations to the histone acetylation and TF landscape. In Aim 2, using these
cells and KAT6A inhibitors, I will quantify changes in select cellular phenotypes using high throughput methods
to deconvolute the negative phenotypic consequences of losing KAT6A function during neuronal differentiation.
Together, these aims utilize orthogonal approaches in human stem cells to identify the molecular and
cellular mechanisms underpinning KAT6A’s function in human in vitro ND and ARTHS neuropathology.

Public health relevance
PROJECT NARRATIVE (Limit: Three sentences) The KAT6A gene is a key epigenetic regulator of human neurodevelopment, causing a rare monogenic neurodevelopmental disorder (NDD) called Arboleda-Tham Syndrome (ARTHS, OMIM#616268) when mutated in utero. This project will enhance our currently-sparse mechanistic understanding of KAT6A’s influence on gene regulation & cell phenotypes during human in vitro neurodevelopment to identify potential therapies for ARTHS -- thereby serving as a framework for other monogenic NDDs. Our approach identifies the effects of nonsense KAT6A mutations (i.e. protein-truncating) on gene regulation & cell phenotypes during neuronal differentiation using cutting-edge omics technologies and novel ARTHS induced pluripotent stem cells, followed by orthogonal validation of key findings using KAT6A-specific loss-of-function inhibitors.